Endovascular blood pressure targeting in cardiac arrest, a translational research study

PROJECT SUMMARY / ABSTRACT
500,000 people in the United States suffer from a cardiac arrest every year. Many patients may be initially
resuscitated from the arrest but go on to die later in the hospital or to have a poor neurologic outcome from
cerebral ischemia. The primary medication used during cardiac arrest care, epinephrine, has been proven to
improve the chance that the heart will restart, but there is developing evidence that it makes neurologic
outcomes worse due to vasoconstriction in the cerebral vasculature. New therapies that can improve blood
flow to the heart and to the brain during CPR, and then maintain that increased perfusion after the heart
restarts, are needed. This study will test a new endovascular therapy that can augment perfusion to the heart
and brain and to decrease epinephrine requirements after the heart has restarted. Endovascular Perfusion
Augmentation for Critical Care, EPACC, is a small aortic balloon catheter that is placed retrograde from the
femoral artery into the proximal descending aorta. Using only partial inflation of the balloon, the device acts like
a “resistor” in the aorta to control blood pressure above the balloon while continuing to permit flow past the
balloon. Balloon inflation and deflation is automated through a series of algorithms that allow the balloon to
rapidly tailor balloon volume movements to the patient’s physiology. A recent small pilot study in a pig model of
cardiac arrest demonstrated that EVAC can decrease the rate of rearrest from 60% to 0% in the early period
after the heart has restarted. This study will model the first 24 hours of post-arrest resuscitation and critical
care in a pig model of cardiac arrest with and without EPACC. Specifically, Aim 1 of this proposed research
will study the effects of EPACC on the heart and the rate of rearrest, Aim 2 will study the effects of EPACC on
the brain and on cerebral perfusion, and Aim 3 will study the effects of EPACC on organs distal to the balloon.
This proposed work will identify the potential benefits of EPACC during post-cardiac arrest care and provide
the foundation for future clinical trials if found to be effective.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Epinephrine is the primary medication used when treating patients suffering from a cardiac arrest despite developing evidence that epinephrine may make neurologic outcomes worse. The objective of this study is to test a new endovascular therapy that can improve perfusion to the heart and brain in patients who have suffered a cardiac arrest. The results from this study will provide a greater understanding of the effects of epinephrine on the brain in cardiac arrest as well as provide the data required to determine if clinical trials of this endovascular therapy are warranted in cardiac arrest victims.